EFFICACY OF ORAL TORSEMIDE IN PATIENTS WITH CHRONIC RENAL INSUFFICIENCY

The purpose of this study is to show that in patients with chronic renal insufficiency, torsemide is effective in preventing fluid reaccumulation when administered over a long enough period that steady state fluid balance has been reached.